BMT-CARE: Multimodal Psychosocial Intervention for Caregivers of Patients Undergoing Hematopoietic Stem Cell Transplantation

PROJECT SUMMARY/ABSTRACT
Overview: The goal of this study is to demonstrate the efficacy of a cognitive-behaviorally based psychosocial
intervention (BMT-CARE) compared to usual care for caregivers of patients undergoing hematopoietic stem cell
transplantation (HCT) and to identify critical facilitators and barriers for intervention implementation and adoption.
Background: Family and friend caregivers of patients undergoing HCT experience substantial distress before
HCT as they cope with the uncertainty of the patient’s prognosis, and the patient endures significant toxicities.
Additionally, as the primary caregivers of patients during the immediate post-HCT course, caregivers often man-
age a demanding schedule of appointments and experience substantial caregiving burden interfering with their
personal lives and responsibilities. Since these individuals experience intense and specialized caregiving burden
which persists before, during, and for several months after HCT, there is a critical need to develop a population-
specific intervention to address their needs across the transplant continuum. However, scalable interventions to
support caregivers throughout the patients’ HCT course are lacking. We completed a single center pilot trial of
BMT-CARE to address the needs of caregivers prior to, during, and after HCT, which entailed six one-hour visits
with a trained study therapist during the HCT course. We demonstrated that the intervention was feasible and
preliminarily led to clinically significant improvement in caregivers’ quality of life, mood, caregiving burden, self-
efficacy, and coping skills. Thus, this was the first trial to establish both the feasibility and preliminary efficacy of
BMT-CARE for improving outcomes of caregivers of HCT recipients.
Research Plan: We propose to conduct a hybrid type I multi-site randomized effectiveness-implementation trial
in 400 caregiver-patient dyads undergoing HCT to test the efficacy of BMT-CARE vs. usual care for improving
caregiver QOL, caregiving burden, mood, coping, and self-efficacy. We will also examine the impact of BMT-
CARE on patient-reported outcomes and health care utilization. Finally, we will identify critical facilitators and
barriers for BMT-CARE implementation and adoption using the RE-AIM QuEST mixed-methods framework.
Environment: This project will be conducted at the Massachusetts General Hospital (MGH), University of Ala-
bama at Birmingham, and Moffitt Cancer Center, which collectively conduct 350-400 transplants per year. These
sites have the supportive oncology research expertise and infrastructure, transplant experience, and processes
to conduct this trial. The MGH research team has the expertise in developing and testing multi-site palliative and
supportive care interventions for patients with hematologic malignancies and their caregivers to ensure the suc-
cessful implementation and evaluation of BMT-CARE across study sites.
Relevance of Research: This project will establish the essential foundation for a future implementation and
dissemination trial of BMT-CARE into clinical practice.

Public health relevance
PROJECT NARRATIVE Family and friend caregivers of patients undergoing hematopoietic stem cell transplantation (HCT) confront substantial psychological and caregiving burden as they provide support for patients during a prolonged transplant hospitalization, manage complex medications and weekly outpatient medical appointment schedules during an intense post-transplant recovery period, and cope with the uncertainty of the patient’s long-term prognosis. Despite the immense physical and psychological burden placed on these caregivers, interventions to address the needs of this vulnerable population are lacking. This proposal seeks to assess the efficacy and potential for scalability and implementation of a psychosocial intervention (BMT-CARE) to provide caregivers of patients undergoing HCT with the skills to effectively cope with the patients’ illness with the goals of improving caregivers’ quality of life, mood, burden, and self-efficacy, patient-reported psychosocial outcomes, and patients’ and caregivers’ health care utilization.